The Center for Advancing Point of Care in Heart, Lung, Blood and Sleep Diseases

Project Summary/Abstract – Overall Core
American healthcare is rapidly evolving to a state where efficiency, quality and patient satisfaction are dominant
drivers. Several trends are driving fundamental changes in health care: 1) an expanding scope of virtual care
and telemedicine, accelerated by the COVID-19 pandemic, has changed how patients, healthcare providers,
and health systems interact; 2) a growing recognition of disparities leading to an emphasis in providing healthcare
equitably for historically marginalized populations; 3) an increasing appreciation for the patient as a critical
stakeholder in therapeutic decision-making, leading to an emphasis on patient-centered design; and 4)
increasing access to home health to enable better diagnosis, prevention and management of health conditions,
as illustrated by widespread adoption of home-testing for SARS-CoV-2. Despite this rapidly changing
environment, heart (cardiovascular), lung, blood, and sleep disorders (HLBS) continue to cause significant
morbidity, mortality, and cost in the US and worldwide. Combined, these diseases account for 41% of deaths in
the US and lead to over $400B in direct health care expenses plus lost income to affected patients and
caregivers. Thus, there are urgent unmet needs in HLBS. We will address these issues with the renewal of the
Center for Advancing Point of Care Technologies (CAPCaT) in HLBS Disorders. CAPCaT is a highly successful
Point-of-Care Technology Research Network (POCTRN) Center that leverages our experience running a
medical product incubator, the Massachusetts Medical Device Development Center (M2D2) at the University of
Massachusetts (Lowell and Worcester campuses), and our experience administering grants, running, and
managing solicitations, and working 1:1 with awardees to advance their technologies toward commercialization.
CAPCaT expanded upon the original vision and success of M2D2 and now has its own established track record
and collaborative network to develop and optimize novel POC and home-based technologies to improve the
diagnosis and management of HLBS disorders. Our objectives in achieving this goal are to continue: 1)
identifying, through stakeholder engagement, the most promising POC and home-based technologies to address
unmet medical needs; 2) supporting developmental plans, including pathways to adoption at the point of care or
in the home; and 3) training and disseminating developing POC and home-based technologies to the different
stakeholders.

Public health relevance
PROJECT NARRATIVE The Center for Advancing Point of Care Technologies (CAPCaT) in Heart, Lung and Blood Diseases will develop and optimize novel point of care and home-based technologies to improve the diagnosis and management of heart, lung, blood and sleep (HLBS) disorders. CAPCaT will accomplish this goal by integrating scientific, technology incubation, business development, trial design, and clinical expertise to identify promising medical products and mentor small companies through alliances with external partners and large companies.